Physiological and Molecular Mechanisms of Impaired PV Circuit Homeostasis in Autism Mouse Models

PROJECT SUMMARY
Parvalbumin (PV) neuron hypofunction and increased excitation-inhibition (E-I) ratio in feedforward
cortical circuits likely contribute to abnormal sensory processing in Autism Spectrum Disorders, but the origins
and molecular mechanisms of PV hypofunction, and its generalizability beyond feedforward circuits, remain
unclear. Here, I will test the hypothesis that PV circuit hypofunction arises because of impaired homeostatic
plasticity of PV circuits, that normally acts to maintain cortical excitability during periods of shifting sensory
input. In L2/3 of whisker primary somatosensory cortex (S1), PV circuit homeostasis is robustly engaged by
brief whisker deprivation, which reduces intrinsic excitability of PV neurons, decreasing feedforward inhibition.
In Aim 1.1, I will use in vitro electrophysiological measurements of PV cell excitability to test for impaired PV
circuit homeostasis in two ASD mouse models (Fmr1-/y and Tsc2+/-). These models share PV hypofunction but
differ in several molecular and synaptic phenotypes, making them a powerful test case for whether the PV
hypofunction may arise from a common source.
Previous physiological studies have primarily focused on dysfunction in bottom-up feedforward circuits
in ASDs, but recent reports in people with ASDs suggest that sensory processing issues may result from a
functional deficiency in top-down feedback pathways, resulting in overreliance on feedforward input. Top-down
pathways provide strong input to S1, but it is unknown whether the physiology of feedback pathways is altered
in ASD mouse models and whether their alteration may also result from a failure of homeostasis in PV cells. In
Aims 1.2 & 1.3, I will assess changes in baseline function and homeostatic plasticity of S2->S1 inputs to L2/3
pyramidal and PV cells in S1 using optogenetics.
Understanding the molecular mechanisms that underlie impaired PV circuit homeostasis in ASDs may
enable therapeutic interventions to restore PV circuit function. These molecular mechanisms are currently
unknown. I will identify the molecular mechanisms underlying deprivation-induced weakening of PV intrinsic
excitability, the key initial step in PV homeostasis. This is known to involve an increase in voltage-gated
potassium (Kv) channel currents. The molecular mechanisms likely involve activity-dependent protein
synthesis, which is reportedly dysregulated in both the Fmr1-/y and Tsc2+/- mice, though potentially in opposite
directions. A promising candidate signaling pathway that could mediate PV circuit homeostasis is activity-
dependent synthesis of transcription factor ER81 leading to increased Kv1.1 expression in PV cells. In Aim 2, I
will use novel cell-specific genetic strategies to test the hypothesis that PV circuit homeostasis requires protein
synthesis in vivo and involves activity-dependent synthesis of ER81 and increased Kv1.1- and this is impaired
in ASD mice. I will also develop CRISPR tools to modulate Kv1.1 levels to rescue PV homeostasis in ASD
mice, potentially leading to therapeutic approaches for ASDs.

Public health relevance
PROJECT NARRATIVE Hypofunction of parvalbumin (PV)-positive inhibitory interneuron circuits and imbalanced excitation-inhibition (E-I) ratio in feedforward sensory pathways likely contribute to abnormal sensory processing, including tactile hypersensitivity, in Autism Spectrum Disorders (ASDs), but the source of PV circuit hypofunction, the molecular mechanisms involved, and the generalizability beyond feedforward circuits remains unclear. I will address these knowledge gaps by asking: (1) Does PV hypofunction arise from defective homeostatic plasticity within PV circuits, possibly related to a broad impairment of cellular homeostasis in ASD? (2) What transcriptional and translational mechanisms mediate PV circuit homeostasis, are these abnormal in ASDs, and can they be rescued by novel CRISPR-based strategies? (3) Do top-down feedback sensory projections exhibit abnormal PV inhibition? Answering these questions will provide fundamental new knowledge about the mechanisms and commonalities of PV circuit deficits in multiple genetic models of ASD, and may lead to new therapeutic approaches to normalize cortical circuit function across ASDs.